The regulation of mutant p53 protein accumulation in cancer: molecular basis and therapeutic potential

Abstract
Tumor suppressor p53 is the most frequently mutated gene in human cancer, including colorectal cancer
(CRC). Many tumor-associated mutant p53 (mutp53) proteins not only lose the tumor suppressive function
of wild-type p53, but also gain new oncogenic activities to promote tumorigenesis, which is defined as the
“gain-of-function” (GOF). Mutp53 proteins often become stable and accumulate to very high levels in
cancer, which is critical for mutp53 GOF in tumorigenesis. Destabilizing mutp53 protein is being actively
tested as a novel and promising strategy for cancer therapy. However, the mechanism of mutp53
accumulation in cancer is poorly understood, which hinders the development of effective strategies for
cancer therapy. MDM2 is the most critical negative regulator of p53. MDM2 isoform B (MDM2B), a spliced
isoform of MDM2, is frequently overexpressed in human cancer, and plays an important role in
tumorigenesis. Currently, the mechanisms underlying MDM2B-mediated mutp53 accumulation and
MDM2B overexpression in cancer are poorly understood. Identifying their underlying mechanisms has the
direct potential to develop effective strategies to treat cancers carrying mutp53. The goal of this study is to
determine the mechanism of mutp53 accumulation in CRC to provide novel therapeutic targets/strategies
for CRC carrying mutp53. Based on our preliminary studies, we hypothesize that MDM2B overexpression
is a critical mechanism underlying mutp53 protein accumulation and GOF in CRC, and furthermore,
MDM2B and its signaling pathway can be targeted for therapy in CRC carrying mutp53. We will test our
hypothesis by following specific aims: 1) determine whether MDM2B overexpression is a critical mechanism
underlying mutp53 accumulation and GOF in CRC using different mouse colorectal tumor models, and
identify mechanisms underlying MDM2B-mediated mutp53 accumulation; and 2) identify mechanisms
underlying MDM2B overexpression in CRC, and test whether targeting MDM2B and its signaling pathway
can inhibit mutp53 accumulation and GOF in CRC. We anticipate that this proposed study will provide new
paradigms regarding mutp53 accumulation, tumor-promoting function of MDM2B, and MDM2B
overexpression in CRC. If accomplished successfully, results from this study will have potential to develop
MDM2B and its signaling pathway as novel therapeutic targets for CRC carrying mutp53.

Public health relevance
Project Narrative Mutant p53 protein accumulation and MDM2B overexpression in cancer play critical roles in tumorigenesis. Currently, the mechanisms underlying mutant p53 accumulation in cancer and the tumor-promoting function of MDM2B are poorly understood. This proposed study aims to determine the role and mechanism of MDM2B in promoting mutant p53 accumulation and gain- of-function in tumorigenesis, and reveal the mechanism of MDM2B overexpression in cancer, which is crucial for the development of novel therapeutic targets and strategies for cancer carrying mutant p53.